NIPreps: integrating neuroimaging preprocessing workflows across modalities, populations, and species

We propose the NeuroImaging Preprocessing workflows ("NIPreps") framework, a workbench for the
development of workflows and visualization tools for the preprocessing neuroimaging data. NiPreps expands
our fMRIPrep software to operate on new imaging modalities and disciplines (e.g., preclinical imaging).
Despite some remarkable analysis workflows that display end-to-end consolidation, integrations across
applications (e.g., analyses of human and nonhuman data) remain exceptionally challenging. Next-generation
neuroimaging workflows require harmonizing measures of wide-ranging phenomena (morphometry,
functional activity, and connectivity) from multiple sources (e.g., scanning centers or modalities).
Hence, we will evolve fMRIPrep into NiPreps, a software framework integrating BIDS and following the
BIDS-Apps specifications. First, the project will consolidate the foundations of the NiPreps integration, with
the generalization of fMRIPrep's driving principles and methods across modalities and domains of application.
Second, we will expand the portfolio of end-user NiPreps with diffusion, arterial spin labeling (ASL), and
molecular imaging "-Preps." Finally, we will address the consolidation of the NiPreps community to ensure
the sustainability of the framework, converging the communities around fMRIPrep, dMRIPrep, ASLPrep, and
PETPrep with hackathons and docusprints. In short, NIPreps will pave the way towards next-generation
imaging, ultimately allowing neuroscientists to seek for a unified statistical framework that is capable of
rigorously integrating cross-application and cross-species data analysis.

Public health relevance
Next-generation neuroimaging analyses will require integrating measures (structural morphometry, functional activity, and connectivity) across disciplines (e.g., brain development, animal models, neuropsychiatric disorders, etc.). Leveraging the support of the BIDS ecosystem of standards, we will develop NIPreps, a collection of BIDS-Apps that generalize the currently existing image preprocessing core of fMRIPrep across data types. By addressing current bottlenecks in the neuroimaging research workflow that impede integration, e.g., consistent multimodal analyses of inhomogeneous data, NiPreps opens new avenues for integrative and reproducible analysis, ultimately enabling the kinds of translation that are essential to maximizing the benefits of the investments in research on the brain and mental health disorders.